Core A - Administrative, Mentoring and Education Core

CORE A – ADMINISTRATIVE, MENTORING AND EDUCATION CORE
SUMMARY/ABSTRACT
The Cardiorenal and Metabolic Diseases Research Center (CMDRC) has diverse functions and is comprised
of multiple components, including research projects of 4 investigators, a Pilot Grants Program, a Mentoring and
Education Program, administrative units, and two Research Resources Cores. Core A provides administrative
support and coordinates all Center activities, develops and implements mentoring and education programs,
and interfaces with the NIGMS, University of Mississippi Medical Center (UMMC) administration, the UMMC
Grants and Contracts office, the departments represented in the CMDRC, and the investigators and trainees of
the Center. Specific functions of Core A are: 1) to provide leadership for enhancement of infrastructure,
mentoring programs, and core facilities that foster research excellence and lead to development of an
internationally recognized CMDRC; 2) to develop, implement and monitor a Mentoring and Education Program
that facilitates progress of the research projects and development of the junior/early career investigators (ECI)
into independent, funded researchers who are also effective collaborators on multidisciplinary research teams;
3) to further enhance the Pilot Grants Program for promising new investigators, with emphasis on recruiting
and mentoring underrepresented minority (URM) investigators; 4) to further develop and implement
educational programs that facilitate collaborations and interactions among investigators from multiple
disciplines at UMMC, as well as with external partners; 5) to develop and implement programs for recruiting,
training, and mentoring a diverse group of postdoctoral fellows, undergraduate and graduate student trainees
to become the next generation of CMDRC researchers; 6) to provide formative and summative evaluation
strategies for progress and effectiveness of all CMDRC programs and Cores; 7) to provide high-level program
administrative support to the research project and pilot grant investigators and core directors; 8) to provide
fiscal oversight of all research projects and cores and central services for purchasing; 9) to further develop and
maintain the CMDRC website, provide assistance to investigators in design and operation of their computer
systems, insure that all data and documents are securely stored on the server and on external drives, install
new software and make minor repairs of computer equipment for CMDRC investigators; 10) to develop and
implement mechanisms for effective communication among the Center investigators, Core leaders, Center
staff, External Advisory Board (EAB), Internal Advisory Board (IAB), and Executive Committee, other centers
within UMMC, and external partner institutions; 11) to organize scientific meetings and seminars related to the
CMDRC as well as meetings of the EAB, IAB, and Executive Committee, and an annual retreat/symposium;
12) to ensure that all CMDRC programs, initiatives, policies and reporting mechanisms are optimally
developed, implemented, and administered within federal granting agency policies and deadlines.

Public health relevance
CORE A – ADMINISTRATIVE, MENTORING AND EDUCATION CORE NARRATIVE The CMDRC has diverse functions and is comprised of multiple components, including 4 investigator research projects, a Pilot Grants Program, a Mentoring and Education Program, administrative units, and two Research Resources Cores. Essential functions of the Administrative, Mentoring and Education Core A are to coordinate and facilitate activities of these components, and provide support for all Center related activities. Core A will further develop and implement mentoring and education programs for investigators and trainees of the Center, and interface with the NIGMS, the University of Mississippi Medical Center (UMMC) administration, the UMMC Grants and Contracts office, the departments represented in the CMDRC, other Centers at UMMC with shared research interests, and partner institutions.